Assessment of Cochlear Dysfunction in Black and White Adults with Stage 2 Hypertension Using High-Frequency Distortion Product Otoacoustic Emissions

Little is known about the relationship between hypertension (HTN) and auditory dysfunction in the Black adult
population and to what extent it differs from that in White persons. Experimental work shows the cochlea is
irreversibly damaged in HTN, making early identification of cochlear dysfunction in persons with this modifiable
condition critical to reducing the disease burden of age-related hearing loss (ARHL). It is also known that HTN
disproportionately affects Black persons. The long-term goal of this line of research is to reduce the public health
burden of ARHL by devising clinical efforts for early identification and intervention of persons with modifiable
determinants of acquired hearing loss. The overall objective of this application is to assess cochlear function in
Stage 2 HTN (a severe elevation in blood pressure) and characterize differences in this relationship between
Black and White adults. The central hypothesis, supported by past studies and the applicant’s preliminary data,
is that, compared to normotensives, outer hair cell health is compromised in persons with Stage 2 HTN and that
White adults experience greater compromise than Black adults. The rationale for this work is that once the extent
of auditory damage in Stage 2 HTN is determined, clinical protocols for early evaluation of auditory vulnerability
in persons with HTN can be established, which will support earlier intervention.
The central hypothesis will be tested by pursuing two specific aims: (1) assess functional integrity of the cochlea
in persons with Stage 2 HTN and (2) characterize Black-White differences in the association between Stage 2
HTN and cochlear dysfunction. Adults aged 18-85 years with normal blood pressure (controls) or Stage 2 HTN
will undergo extensive behavioral and swept-tone distortion product otoacoustic emission (DPOAE) testing.
Under Aim 1, swept-tone DPOAEs will be collected from f2 of 1-20 kHz. Under Aim 2, linear mixed effects
modeling will disentangle the effects of HTN, race, sex, and potential confounders on auditory function with a
focus on cochlear health. Innovation aspects of this research include the methodological approach (swept-tone
high-frequency DPOAEs), statistical modeling (which will disambiguate the effects of HTN from other contributors
to ARHL), and assessment of racial differences. The proposed research is significant because it is a vital step
in devising clinical efforts for early identification and intervention of persons with modifiable determinants of
acquired hearing loss and will provide critically needed data on cochlear dysfunction in Black adults, a historically
under-studied population. Capturing auditory dysfunction early in the disease process is important because
hearing loss, even in the subclinical stage, is associated with negative outcomes. Ultimately, knowledge gained
from this research will inform development of clinical tools and protocols to improve early identification of auditory
dysfunction in persons with medical comorbidities such as Stage 2 HTN with the end goal of advancing more
effective therapeutic solutions.

Public health relevance
NARRATIVE The proposed research is relevant to public health because it fills a gap in our understanding of modifiable determinants of acquired hearing loss. This work will characterize Black-White differences in cochleopathy associated with Stage 2 Hypertension, a chronic condition that is most prevalent in the Black population. This research will produce a positive impact through providing reliable data regarding the link between HTN and cochlear vulnerability and will support future development of timely audiological assessment and responsive interventions, especially in underserved populations.